Disease Modeling Core

DISEASE MODELING CORE
PROJECT SUMMARY/ABSTRACT
The overall mission of the Disease Modeling Core (DM core) is to provide diabetes researchers with access to
novel human stem cell-derived in vitro cell models for investigating cellular and molecular features of both Type
1 and Type 2 diabetes. Recent progress in stem cell, organoid culture, gene editing and directed differentiation
technologies has afforded opportunities to develop state-of-the-art pre-clinical human models. However,
because of the complex experimental protocols and specialized reagents used, together with the considerable
up-front costs and time required to develop these sophisticated stem cell-based models, it is not practical nor
cost-effective to develop these models in individual laboratories. The goal of DM core is to provide the expertise,
infrastructure and access to novel human model systems and technologies to DRC investigators. To help
overcome the obstacles faced by basic scientists and clinical researchers who wish to establish human stem cell
approaches in their laboratories, we will provide expertise, resources and training in start-of-the-art stem cell
technologies together with rigorous quality control testing, validation standardization and authentication all model
platforms and reagents. This goal will be achieved in three ways: 1) providing access and training in current and
emerging pluripotent and adult stem cell technologies for in vitro human disease modeling, including the use of
organoids; 2) providing access, training and implementation of genome editing technology, directed cell
differentiation/programming, and gene expression systems; and 3) providing validation, authentication and data
sharing of all DM-related technologies. Thus, the overall mission of this core is to facilitate access, generation
and usage of novel human stem cell-derived in vitro models to promote basic and translational innovative
diabetes research at UC AMC.